SPERM PROTEIN INVOLVED IN BINDING AND FUSION TO EGGS

This research project will study mammalian fertilization, focusing on identifying molecules that mediate the binding and fusion of gamete plasma membranes. Relatively little is known about this developmental timepoint. Recently, a putative ligand on sperm was identified in guinea pig, known as PH-30. However, since the guinea pig system is very intractable for the study of fertilization and egg activation, this research will study the mouse homolog of PH-30, since the mouse system is well-characterized and easy to use. The project has two stages. The first stage will generate reagents that will be used in future experiments; methods used will include isolation of clones from a cDNA library, expression of recombinant protein, and production of antibodies. The second stage of the project will use these reagents to determine if PH-30 binds to eggs, if PH-30 or anti-PH-30 antibodies can inhibit in vitro fertilization, and if specific egg membrane proteins bind to PH-30 in chemical cross-linking experiments. This work has direct applications in the research of assisted fertility treatments and contraceptive techniques.